Multimodal Probabilistic Machine Learning for Uncovering Latent Factors of Resilience in Alzheimer’s Disease

PROJECT SUMMARY
The complex etiology underlying cognitive aging, Alzheimer’s disease (AD), and AD-related dementias (ADRD)
involves factors across biological scales that are highly dynamic and interdependent. A deeper mechanistic
understanding of individual differences in disease is likely to accelerate the design of new therapies. This requires
examining data across multiple genetic and environmental contexts, and across multiple data modalities
simultaneously (molecular, anatomic, functional imaging, cognitive assays under stress and throughout aging).
Identifying targetable disease factors from such high-dimensional and multimodal datasets is a big data
challenge, in part due to the immense search space of possible underlying factors to cognitive resiliency. And
even once a latent factor or set of factors is hypothesized, such claims must be causally investigated – a slow,
expensive undertaking. Here, we aim to develop novel multimodal variational autoencoder (VAE) models that
learn factors associated with cognitive resilience to AD. We will employ generative methods to not just discover
new factors from existing data but also identify dynamic relationships among factors in the learned latent space.
Our model will enable us to predict the effects of perturbations to the latent factors and offer a means of testing
complex genetic or environmental interventions prior to investing effort experimentally. In Aim 1, we will develop
a multimodal VAE to shape a resiliency-susceptibility latent space and model dynamical features contributing to
both the onset and progression of cognitive aging across short and long timescales. In Aim 2, we will incorporate
Bayesian hierarchical layers to enable iterative updates of new data and employ generative sampling to produce
testable hypotheses of how time or causal interventions change the latents towards resiliency. Finally, in Aim 3
we will validate learned factors via genetic engineering in our diverse panel of AD-BXD mice that better model
heterogeneity of human AD, spanning the spectrum from highly resilient to highly susceptible. We anticipate that
our methods will drastically shorten the model-experiment validation cycle and will lead to novel findings of latent
factors that drive resilience in AD and ADRD and of essential mechanisms for designing new therapies.

Public health relevance
PROJECT NARRATIVE The goal of this research is to develop a multimodal machine learning framework to identify factors associated with cognitive resilience to Alzheimer’s disease and to propose novel interventions via generative trajectories in the learned latent space. Our approach will enable sample-efficient and iterative model inference that can adapt to new data as it is acquired, thereby drastically shortening the model-experiment validation cycle. These models will likely be generalizable to the broad study of the dynamics of aging across diverse data modalities.